GUIDeS Shared Resource

The Partnership for Native American Cancer Prevention (NACP) Shared Resource, Guiding U54
Investigator Development to Sustainability (GUIDeS), organizes and facilitates a range of services, and career
enhancement opportunities, primarily targeted for early-stage investigators (ESIs), junior investigators (JIs),
and postdoctoral scholars (jointly referred to as GUIDeS Participants (GPs), though these resources serve all
investigators in NACP. The overall goal is to equip ESI/JIs for submission of successful R01 level cancer-
related research grants and achieve rewarding academic careers. GUIDeS is focused on promoting Native
American and underrepresented ESI/JIs and postdoctoral scholars to increase representation in cancer health
disparity research. GUIDeS has embraced the two-eyed seeing paradigm, which seeks to “see from one eye
with the strengths of Indigenous knowledges and ways of knowing, and from the other eye with the strengths of
Western knowledges and ways of knowing, and to use both of these eyes together for the benefit of all.” 1
GUIDeS adapts this approach to allow the two perspectives of the GPs and GUIDeS Co-Leaders to meld these
perspectives to promote positive career trajectories. GUIDeS interacts with the other NACP Cores and
research projects to ensure services and expertise across NACP are available to early researchers.
Since its beginning in 2019, GUIDeS supported 29 GPs cancer or health disparity grant proposals and
seven American Indian Alaska Native (AIAN) CURE pipeline submissions, exceeding the NACP 5-year goal to
submit six applications to the CURE pipeline. Since GUIDeS is in its early stages, the adaption of the two-
eyed seeing approach was used to improve the Shared Resource for the next grant cycle.
Aim 1. Increase the development and submission of cancer research grants and manuscripts by
identifying mentors to support GPs in developing a path to successful academic research addressing cancer
disparities among Native Americans.
Aim 2. Provide enhanced analytical support for cancer research by providing GPs with workshops, and
analytical infrastructure to enhance contributions to cancer health disparities research.
Aim 3. Support extended opportunities for professional and career development by providing academic
career planning opportunities for early-stage faculty using a “mapping strategy” to set aside blocks of time for
teaching, writing of grants and publications. GUIDeS will assist in navigating the university promotion and
tenure process, development of R01-level research, and promoting work-life balance.